ROLE OF NITRIC OXIDE IN THE PATHOGENESIS OF LUNG DISEASE

Human inducible nitric oxide synthase (hiNOS) is responsible for nitric oxide (NO) synthesis in response to inflammatory mediators. Regulation of (hiNOS) occurs predominantly at the transcriptional level. The proximal 8296-bp region of the hiNOS promoter contains many potential cytokine-response elements including those for AP-1 and NF-kB. AP-1 and NF-kB are ubiquitous transcription factors and pleiotropic regulators of many genes encoding proteins involved in the modulation of inflammatory and host defense processes in eukaryotic cells. The involvement of AP-1 and NF-kB transcription factors in cytokine-mediated induction of human inducible nitric oxide synthase (hiNOS) promoter activity was examined. Luciferase reporter plasmids, containing mutations in AP-1 and NF-kB sites, were transiently expressed in A549 cells (a human lung epithelial adenocarcinoma cell line) and promoter activity was determined after treatment with CM (a cytokine mixture containing IL-1beta, IFN-gamma, and TNF-alpha). Mutation of the AP-1 heptad -5301 bp upstream of the transcription start site decreased gene activation by 90%. Disruption of AP-1 (at -5115), and NF-kB (at -115 and -8283) sites resulted in reduction of promoter activity by 45%, 67%, and 52%, respectively. Responsiveness to CM was reduced by 85% in constructs mutated in both NF-kB sites. Gel retardation analyses revealed that CM increased AP-1- and NF-kB- binding. With NF-kB sequences, protein/DNA complexes were observed only after treatment with CM. Induction was highest when first tested at 1 h and decreased with longer stimulation. In contrast, constitutive AP-1-binding was found in untreated cells and cytokine stimulation increased binding in a biphasic manner; with maximal binding at 3 and 24 h. Supershift analysis identified Jun D and Fra-2 as components of AP-1 complexes. Interestingly, each kB site bound different complements of NF-kB/Rel family members (proximal site, Rel A/p50; distal site, Rel A/Rel A). At the protein level, Jun D and p50 were constitutively expressed and Fra 2 was induced in CM-treated cells. In agreement with the current model of NF-kB regulation, Rel A was maximally, while IkB-alpha was minimally, expressed in nuclei after 1 h of CM treatment, corresponding with the peak in NF-kB-binding activity. Altogether, these findings suggest that AP-1 and NF-kB are important cis-elements in the transcriptional induction of hiNOS gene by cytokines in A549 cells.